Mechanisms of uterine artery hemodynamics adaptation to pregnancy and gestational hypoxia

Project Summary
Pregnancy is associated with a striking increase of uterine blood flow that is essential for normal fetal
development as well as for cardiovascular well-being of the mother. Hypoxia during pregnancy has profound
adverse effects on uterine artery hemodynamics adaptation, increasing incidence of pregnancy complications
including preeclampsia and fetal intrauterine growth restriction. Previous studies in an animal model of pregnant
sheep acclimatized to high altitude hypoxia demonstrated that pregnant ewes were similar to pregnant women
in that they both showed an increase in uterine vascular resistance and elevation in maternal systemic blood
pressure in response to gestational hypoxia. Yet, much remains unknown of the mechanisms underlying
maternal cardiovascular maladaptation to chronic hypoxia during pregnancy. Our preliminary study in sheep
suggests a highly novel mechanism of a monomeric G protein, Rad in inhibition of L-type CaV1.2 calcium channel
currents in the uterine artery. The L-type CaV1.2 calcium channel, as the major pathway of Ca2+ influx, is essential
for vascular smooth muscle contractions and plays a central role in regulating organ blood flow and arterial
pressure. We identify that both ovine and human Rad gene promoters have multiple estrogen response elements
(EREs), suggesting a robust mechanism of sex steroid hormones in the regulation of Rad gene expression in
the uterine artery. In addition, the approach of RNA-seq analysis revealed a downregulation of Rad gene
expression in uterine arteries of pregnant ewes acclimatized to high altitude hypoxia. Of importance, we
demonstrated that chronic hypoxia during gestation abrogated pregnancy-induced upregulation of Rad protein
expression and increased CaV1.2 channel currents in ovine uterine arteries. These exciting findings and many
highly novel leads provide a strong scientific premise for us to move the field forward significantly by launching
a new focus of research aimed at understanding the molecular and epigenetic mechanisms of Rad in regulating
CaV1.2 channel currents and phenotypic programming of uterine vascular adaptation to pregnancy and
gestational hypoxia. The proposed study will be conducted in a unique animal model of pregnant sheep exposed
to high altitude (3801 m/12,470 ft) hypoxia during gestation. The overall hypothesis of the proposed study is that
Rad is a novel regulatory mechanism and plays an essential role in the regulation of L-type CaV1.2 calcium
channel currents and uterine vascular adaptation to pregnancy and gestational hypoxia. The proposed study
has the strong scientific premise with a novel conceptual framework and mechanistic approach. It will provide
new insights into fundamental mechanisms in uterine vascular adaptation to pregnancy, and will have a major
impact on our understanding of pathophysiologic mechanisms underlying pregnancy complications including
preeclampsia caused by gestational hypoxia. Of importance, the similarity in uterine artery hemodynamics and
maternal blood pressure responses to gestational hypoxia between pregnant ewes and pregnant women, as
well as likely common mechanisms of Rad gene regulation by sex steroid hormones, will provide much needed
translational relevance of the proposed study in the understanding of maternal cardiovascular complications in
response to hypoxia during pregnancy.

Public health relevance
Program Narrative Pregnancy is associated with a striking increase of uterine blood flow that is essential for normal fetal development as well as for cardiovascular well-being of the mother. Hypoxia during pregnancy has profound adverse effects on uterine artery hemodynamics adaptation, increasing incidence of pregnancy complications of preeclampsia and fetal intrauterine growth restriction. Yet, much remains unknown of the mechanisms underlying maternal cardiovascular adaptation to chronic hypoxia during pregnancy. Scientifically, the proposed study will augment our understanding of basic mechanisms whereby maternal cardiovascular system adapts to pregnancy and gestational hypoxia. From a clinical standpoint, the study will provide new insights and suggest new directions in the management of pregnancy complications and abnormal fetal development associated with gestational hypoxia, thereby reducing perinatal morbidity and mortality while improving maternal health and neonatal outcome.